Investigations of Proteome Turnover Kinetics Under Cellular Differentiation

PROJECT SUMMARY
This administrative supplement application is being submitted to PA-20-272 in accordance with NOT-GM-
24-021. The scope of the parent project remains unchanged. Summary of Parent Project R35-GM146815:
Proteins are in a constant flux of continuous synthesis and degradation. Both components of the protein
turnover cycle contribute to protein abundance. Although this fact has been known for 80 years, currently
most biological inquiries are limited to static snapshots of overall transcript and protein levels, whereas
knowledge into the dynamic changes of protein turnover remains severely lagging. This ESI MIRA proposal
seeks to advance the current understanding of how cellular proteomes remodel during cell state transitions,
by incorporating protein turnover kinetics information at key stages of human induced pluripotent stem cell
(iPSC) differentiation into distinct cellular lineages. Working with collaborators, we previously developed
deuterium stable isotope labeling, mass spectrometry, and kinetic modeling methods to quantitate protein
turnover in animal models and in human. In doing so, we found many novel cell states and disease markers
may be discovered from integrating orthogonal protein abundance and kinetics information. In the next five
years, we propose to: (1) apply these methods to acquire a high temporal density map of human iPSC
trilineage differentiation into cardiomyocyte, hepatocyte, and neuroprogenitor cells; (2) interrogate the
regulatory principles that govern turnover flux across different differentiation stages; and (3) assess the
functional consequences of protein degradation on the success and cell maturity of terminal cell production.
Finally, a limitation of current techniques is that the kinetic models used in protein turnover studies largely
assume a non-changing protein pool size at steady state, which does not apply to differentiating cells or
progressing diseases. We propose to expand current models of analyzing heavy water stable isotope label
experiments toward dynamical systems with variable protein pool sizes. If successful, the proposed research
would greatly expand the current knowledge of molecular events that take place during human iPSC
differentiation, as well as generate publicly available data sets and software tools to advance protein turnover
studies in diverse areas.

Public health relevance
PROJECT NARRATIVE Narrative of Parent Project R35-GM146815: The composition and concentration of proteins in a cell are tightly regulated to maintain cell identity and ensure physiological functions. We propose to apply stable isotope labeling, mass spectrometry, and kinetic modeling methods to understand how the processes of protein synthesis and degradation are orchestrated during cell state transitions in human induced pluripotent stem cell differentiation into various cell types. The resulting knowledge, data, and software tools have the potential to advance current understanding of cellular differentiation and open new avenues for disease modeling and tissue engineering applications.